Developmental Funds

Developmental Funds
Project Summary
The Purdue University Center for Cancer Research (PCCR) was established as a National Cancer Institute
basic science cancer center in 1978. As a NCI basic science cancer center, the PCCR's mission focuses on
basic discovery - discovery through Foundational Disciplines that the PCCR fosters for innovative cancer
solutions. The PCCR has a robust process for the use of developmental funds. During the last project period,
the PCCR used the developmental funds to further strengthen cancer-related science within the Purdue Center
for Cancer Research (PCCR), primarily through support of faculty recruitment and through support of the
Computational & Medicinal Chemistry Shared Resource (CMC-SR). Through the direction of PCCR leadership,
developmental and additional funds and space were used to directly support recruitment of 10 new faculty (6
junior and 4 senior) into the Cell Identity and Signaling (CIS), and Targets, Structures and Drugs (TSD) Research
Programs. In the proposed project period, the PCCR proposes the following specific aim:
Aim 1: Recruit faculty members into the PCCR, with a major emphasis on faculty in computational
genomics and bioinformatics, and cancer biology. An emphasis will be placed on recruiting senior
investigators in the area of computational biology or cancer therapeutics, as well as in the area of
analytical chemistry and biophysics, with a cancer focus.